Data Science Core

MISSISSIPPI INBRE
DATA SCIENCE CORE
Project Summary/Abstract
With advancements in biomedical research, leveraging diverse aspects of Data Science has become a critical
component to understanding the complexity of biological and epidemiological data. The mission of the MS
INBRE Data Science Core (DSC) is to provide a full-service resource that addresses advanced data analysis
needs to further biomedical research and training infrastructure in MS. The DSC will leverage and expand
infrastructure built by the “Bioinformatics Core” a key component of MS INBRE operations in the current and
prior project periods. The experts assembled from MS Research-Intensive Institutions (RIIs) that make up the
Core are dedicated to enhancing the biomedical research capacity in the state and training students and
faculty in computational tools. The DSC is committed to providing continuing support of bioinformatic needs for
all MS investigators for analysis of “omics” data. It will also begin new initiatives to promote the understanding
and use of artificial intelligence (AI) techniques such as machine learning (ML), Deep learning (DL), and
Convolution Neural Networks (CNNs), and recruit experts in molecular modeling for docking and virtual reality
visualization to improve research and teaching. Additionally, new expertise in biostatistical approaches for
epidemiology and data management will join the MS INBRE. The DSC will continue to work closely with the
Molecular and Genomics Core, Proteomics Core, and metabolomic Core Facilities, which are integrated within
the Instrumentation and Services Core (ISC), to provide expertise to investigators in analyzing complex
biomolecular datasets. With introduction of the DSC, greater support for community-based participatory
research (CBPR) projects with the Community Engagement and Training Core (CETC) will be offered by the
MS INBRE. Critical services provided by the Core include access to commercial software, computational
environments, and training for both research and curriculum development, making the DSC vital to the MS
INBRE's mission to enhance the competitiveness of biomedical research and advance science education in
MS. The following aims were developed to accomplish the goals of the core and complement the MS INBRE
program: 1) To support analysis of “omics” data; 2) promote use of AI; 3) Offer resources for molecular
modeling; and 4) Provide support dataset curation and analysis. At the completion of this project, we expect to
have enhanced the quality of computational resources and training in the state and to have positively impacted
biomedical projects for MS investigators particularly at primarily undergraduate institutions (PUIs).

Public health relevance
Project Narrative: The Mississippi INBRE Data Science Core will provide essential analytical and computational resources that support many programmatic activities. It is a keystone of research infrastructure due to deep integration with other Cores. This will be accomplished by 1) providing bioinformatic support for high throughput data sets from genomics, transcriptomics, proteomics, and metabolomics/lipidomics experiments; 2) Offering training in Artificial intelligence technology to enhance biomedical and community health research; 3) support molecular modeling needs for research and education; and 4) Consult on data management practices for appropriate statistical analysis of data.